Care4AD: A Comprehensive Care Coordination and Management Platform for Alzheimer Disease and Related Dementias

ABSTRACT
Care for persons with dementia requires constant and effective management and coordination of delivery of care
between caregivers and family members. A robust, technology-driven solution for care management and
coordination could significantly reduce the burden of caregiving and improve quality of life for patients with
Alzheimer’s disease (AD). A few attempts have been made to use technology to support care coordination, but
there is no integrated system to support self-care, assist caregivers with care coordination, and facilitate
information sharing within a patient's caregiving team. In response to this need, BioSensics, in collaboration with
Baylor College of Medicine (BCM), proposes to develop a comprehensive care platform called Care4AD™. The
Care4AD platform will allow caregivers to schedule caregiving tasks, monitor physical activity and activities of
daily living (ADL), and facilitate timely completion of ADLs (e.g., taking medication, scheduled toileting, hydration
and meals, and attendance at scheduled appointments) through visual and voice reminders.
Care4AD will consist of four technologies that work in tandem to enable effective care coordination. The
Care4AD app will be used by caregivers to coordinate care, view physical activity and ADL information, and
schedule reminders. The Care4AD tablet serves as a kiosk in the patient’s home to show scheduled activities
and reminders, and it also supports audio reminders and voice recognition. Care4AD tags are a series of
wireless sensors that will be attached to various objects of interest within the home to facilitate the monitoring of
instrumental activities of daily living. Finally, the Care4AD sensor is a wearable sensor (based on existing
commercially available technology from BioSensics) that monitors physical activity and ADLs, collects data from
the tags, and transfers data to the Care4AD tablet, which serves as a data gateway for all the data collected
from the sensor and tags.
BioSensics has the requisite experience to successfully complete this project having developed and
commercialized a sensor-based remote monitoring platform for older adults called PAMSys™. For this project,
we have conducted three preliminary studies using PAMSys to monitor physical activity in individuals with
cognitive impairment. In addition, BioSensics has already developed a prototype of the Care4AD tag, which will
be further refined in this project. In Phase I, we will develop a prototype of the Care4AD platform and carry out
stakeholder interviews to assess the feasibility and acceptability of Care4AD and gather feedback that will be
used to improve the platform. In Phase II, we will complete the development of Care4AD, incorporating feedback
from Phase I, and carry out a randomized controlled clinical study to evaluate if using the Care4AD platform
reduces the burden and stress of caregiving, increases adherence to scheduled ADLs, and improves physical
function and quality of life of patients.

Public health relevance
Project Narrative Dementia, a chronic disease of aging, is characterized by progressive cognitive decline that interferes with independent functioning. The medical, psychological, social and functional sequelae of dementia cause great stress to patients, their caregivers, and their family. We propose to develop a home-based care coordination and management platform to help caregivers effectively coordinate, manage, and improve dementia care.